Noninvasive assessment of IDH mutation status in intrahepatic cholangiocarcinoma

Intrahepatic cholangiocarcinoma (iCCA) is the second most common primary liver malignancy in the United
States and worldwide. iCCA has a dismal prognosis, with just a 20% 5-year survival rate, and the incidence of
this condition has been increasing over the last few decades. Many factors contribute to the poor prognosis of
iCCA, including issues with current diagnostic capabilities and limited treatment options. There has been
significant progress in the last decade in understanding the molecular mechanisms underlying iCCA, including
identifying isocitrate dehydrogenase (IDH) gain of function as one of the most common mutations specific to
iCCA, with R132 being the most common. This mutation results in alpha-ketoglutarate (α-KG) being metabolized
to 2-Hydroxyglutarate (2HG), an oncometabolite and a surrogate marker of the mutation. This mutation provides
the potential for the development of precision medicine strategies for IDH mutant iCCA. Many new therapeutics
for IDH mutant iCCA using small molecule inhibitors of mutant IDH have been developed, with the ClarIDHy trial
showing promising phase III results. However, despite these advances, accurate diagnosis of iCCA, particularly
diagnosing subtypes, remains challenging, slowing the implementation of appropriate treatment strategies.
Current noninvasive diagnostic approaches for iCCA, such as Contrast-Enhanced Ultrasound (CEUS), Magnetic
Resonance Imaging (CE-MRI), and Computed Tomography (CT), have varied reports of sensitivity18–20.
Importantly, these techniques lack high specificity in the 30% of patients who present with cirrhosis, risking a
misdiagnosis of hepatocellular carcinoma (HCC). Furthermore, these imaging techniques cannot determine the
specific subtype of iCCA without invasive procedures. Biopsies, the gold standard for confirming iCCA diagnosis,
have a long turnaround time and may be unsuitable for molecular analysis in up to 20% of cases. Due to these
limitations, there is a clinical need for minimally invasive and fast imaging tools capable of detecting iCCA
with IDH mutation and differentiating iCCA from HCC.
To address this need, we propose the use of hyperpolarized MRI as a novel diagnostic approach for identifying
mIDH-producing iCCA. By leveraging the enhanced sensitivity and spectral characteristics of hyperpolarized
carbon-13 (13C) labeled α-KG and its metabolites, we aim to study the dynamics of mIDH's enzymatic behavior
in vitro and in vivo. We will optimize the imaging parameters for this technique and build towards accurate
noninvasive identification of IDH-mutant iCCA.
Aim 1: Optimize an existing pulse sequence to maximize sensitivity to 2HG through spectral editing.
Aim 2: Characterize the dynamics and sensitivity of hyperpolarized 1-13C diethyl Alpha-ketoglutarate
metabolism in mIDH intrahepatic Cholangiocarcinoma (iCCA) cells.
Aim 3: Noninvasively identify IDH-mutated Cholangiocarcinoma using Hyperpolarized diethyl 1-13C
Alpha-ketoglutarate in patient-derived-xenograft mouse models.

Public health relevance
Relevance to public health Intrahepatic cholangiocarcinoma is a deadly liver cancer with limited treatment options. Recent progress in developing subtype specific treatments have shown the promise of precision medicine for improving outcomes, emphasizing the need for noninvasive diagnosis of thesesubtypes. Leveraging the high sensitivity of hyperpolarized imaging, the proposed work aims to optimize and validate a new approach to bring accurate and rapid diagnostics to patients.